Reduction in frequency of drug use as a primary outcome and its relation to changes in health-related and other functional outcomes in stimulant use disorder trials

Project summary/Abstract: Several issues in the design and analysis of clinical trials of stimulant use disorders have impeded the development and approval of new treatment options. A key issue concerns the reliance on abstinence as the primary outcome. Although abstinence is a clinically relevant endpoint, relatively few trial participants ever achieve enduring abstinence either during treatment or in the 6-12 months post treatment. Moreover, the use of a binary measure of abstinence, relative to a quantitative measure of reduction in frequency of use, entails a significant loss of information and statistical power. One important implication of this loss is that trials with larger sample sizes are required, creating greater challenges for both recruitment and retention. In addition, the statistical analyses of these trials pose a number of challenging issues that, so far, have not been adequately addressed. Primarily, missing data is a formidable problem that is often handled with stopgap methods that yield biased estimates of treatment effects. The overarching goal of the proposed research is to establish that within-treatment reduction in frequency of use, as determined from urine drug screens, is (i) a more sensitive endpoint for assessing the benefits of treatments for stimulant use disorders, and (ii) predictive of longer term post-treatment follow-up measures of drug use and functioning. In doing so, we propose a rigorous statistical approach to the analyses of stimulant use disorder trials that overcomes the missing data challenges highlighted above. Specifically, using five existing clinical trial datasets, the proposed research will provide both statistical and empirical evidence that reduction in frequency of use (based on urine drug screens), rather than abstinence, is a more sensitive endpoint for determining treatment efficacy. In addition, the research will examine the association between within-treatment reduction in frequency of use and longer-term follow-up improvements in measures from five problem domains that have significant societal consequence: (i) legal, (ii) employment, (iii) family, (iv) psychological and (v) medical problems. Finally, the research will determine whether a key set of measures from these problem domains can be selected for use in conjunction with reduction in frequency of use to provide the most salient and clinically meaningful endpoints for clinical trials of stimulant use disorders. Additionally, we plan to make the statistical methodology developed for each aim widely accessible to non- statisticians. Specifically, we will create macros and procedures which can be used with existing statistical software packages (e.g., SAS, Stata, and R). Statistical macros and procedures will be documented and made publicly and freely available to other researchers in the scientific community via our website, together with documentation on how to apply these macros to the example datasets analyzed in the resulting publications.

Public health relevance
Project narrative/Public health relevance statement: The development and approval of new treatments for stimulant use disorders (e.g., cocaine and methamphetamine use disorders) have been hindered by reliance on enduring abstinence as the primary endpoint of clinical trials. The proposed research will assess whether reduction in frequency of drug use can replace abstinence as a clinically relevant endpoint. If this project is successful, it will result in the identification of a far more sensitive endpoint for assessing the effects of new treatments in future clinical trials.